Statistics Core

RESEARCH CORES - STATISTICS
Project Summary/Abstract:
The primary goal of the Statistics Core located at the University of Kentucky is to provide access
to statistics support for experimental design, preparation of manuscripts and grant applications. The
core will also provide statistical training and professional development opportunities for KBRIN
investigators and trainees at UK, through regional conferences, workshops and seminars, and at
each regional university during site visits. We will continue to utilize unique strategies, via the
Applied Statistics Lab (ASL), to bring in new regional investigators into the KBRIN network and
provide statistical expertise for their research. Some of these endeavors include providing easier
access to statistical services through video conferences, on-site visits, and educating
investigators about KBRIN statistical resources. ASL faculty, students, and staff have worked,
and will work, remotely and in person with the regional investigators to supply expertise in
experimental design, statistical analysis, and data management. Finally, with an emphasis on
mentorship and training, ASL graduate students are partnered with an experienced faculty/staff
member who mentors the graduate student through all stages of a project. Training will be in the
areas of data security, data management, data analysis using SAS and R, automatic table
creation, post-hoc analysis, and statistical consultation. In summary, the Statistics Core will
provide the statistical support to develop a highly skilled workforce in the Commonwealth of
Kentucky.